CAPRI: Columbia Cancer Research Training Program for Resident-Investigators

Project Summary/Abstract
This is a proposal to fund an established post-doctoral training program called the Columbia Cancer Research
Training Program for Resident-Investigators (CAPRI) focused on training physician-scientists in translational
cancer medicine at Columbia University Irving Medical Center (CUIMC). Over the past 5 years and with
ongoing institutional support for our CAPRI program, we have trained 11 resident-investigators (RIs) from 6
different clinical departments, including 2 residents from underrepresented minoritized (URM) backgrounds.
For this resubmission, we will expand CAPRI from 2 to 4 RIs per year and we will focus on the largest
residency programs with the majority not having built-in research years. We have successfully recruited
residents from multiple disciplines and leveraged the resources of the Herbert Irving Comprehensive Cancer
Center (HICCC) at CUIMC, including 36 NIH-funded faculty in basic, clinical/translational, and population
sciences and the rich training environment. With the ongoing expansion and institutional commitment to
oncology, we have added over 20 independent investigators to our pool of research preceptors (RPs) who will
provide direct supervision of the trainees. Through new leadership at CUIMC, the thematic research areas of
our Cancer Center focus on precision medicine and cancer health disparities. Recent initiatives, such as the
HICCC Cancer Research Training and Education Coordination (CRTEC) core, provide additional opportunities
for training and career enhancement activities for resident-investigators. In order to increase diversity in the
academic workforce, we have specifically added a Committee for Diversity Enhancement to foster these efforts
within CAPRI. The principal aim of CAPRI is to provide comprehensive training in the design and conduct of
state-of-the-art research to highly motivated physicians (MD or MD-PhD) dedicated to academic careers in
clinical cancer medicine. With an emphasis on multi-disciplinary team science, our goal is to facilitate the
development of translational researchers drawn from 5 CUIMC residency programs, including Medicine,
Pathology, Pediatrics, Radiation Oncology, and Surgery. CAPRI will provide RIs with the advanced skills
necessary to:
1. Design and conduct rigorous hypothesis-driven research that encompasses the cancer care continuum
of prevention, screening, diagnosis, treatment, survivorship, and palliative care with the goals of
reducing morbidity and mortality from this disease and reducing health disparities;
2. Translate promising pre-clinical and observational findings into cancer clinical trials that prospectively
evaluate biological and clinical endpoints, and
3. Conduct clinical cancer research in a multi-disciplinary team setting in which physician-scientists, basic
scientists, and population scientists collaborate and interact to expedite and accelerate the translation
of research findings into the clinical setting.

Public health relevance
Project Narrative Due to the rapid nature of innovation in cancer research, challenges exist in training and retaining physician- scientists conducting rigorous translational research. The Columbia Cancer Research Training Program for Resident-Investigators (CAPRI) addresses the critical shortage of well-trained cancer physicians from multiple disciplines. The continuation of CAPRI, which provides comprehensive research training, will ensure a cadre of future clinical investigators who will conduct high-impact research spanning the cancer care continuum.